VisitBoost: A Home Visiting Enhancement to Reduce Harm for Families Affected by Substance Misuse

Project Summary
Stigmatization of people with substance use disorders (SUD) during perinatal results from the toxic belief that
people who use substances are incapable of being good parents and do not care about their children. This
belief perpetuates cyclical and systemic harm towards people with SUD and their children. Home visiting
programs are less likely to sustain engagement with parents with SUD because those parents experience and
perceive stigmatization. However, home visitors want to do better. Despite home visitors reporting that it is
difficult to support parents with SUD, most home visitors want additional training in this area. Additionally, harm
reduction practices are becoming more common and home visitors want more training to be able to support
parents in this area. The current home visiting programs are not equipped to support parents within this
changing landscape. There is the potential to improve current practices, reduce harm, and improve overall
parent and child outcomes for people with SUD during perinatal by reducing stigmatization within home visiting
programs. This change cannot just be a one-time training for home visitors. It must be a comprehensive
solution to change home visiting organizations including de-implementation of polices that cause harm,
implementation of policies to provide support, leadership education and guidance, identification of community
resources for warm hand-offs, training and support for home visitors, and ongoing opportunities for practice
and reflection. Our proposed solution, VisitBoost, includes strategies to address multiple levels of stigma and
improve home visiting services for people with SUD during perinatal. The overall goal of the proposed Phase I
project is to create VisitBoost and demonstrate feasibility for reducing stigmatization among home visitors
towards clients with SUD. We will accomplish our goal through two specific aims: 1. Use an iterative
formative process to develop a prototype of the VisitBoost mobile application to develop modules to
support de-stigmatization practices among organizational leaders and home visitors. 2. Evaluate VisitBoost
prototype for acceptability, usability, and effectiveness using a mixed-methods program evaluation
approach with our advisory boards. We will assess home visitor attitudes, knowledge, self-efficacy, practices,
practices intentions (post-training only), and usability with 52 home visitors to optimize successful use of the
mobile application.

Public health relevance
Project Narrative This Phase I SBIR proposes a program to enhance home visiting programs to systematically address stigmatization of people with substance use disorders (SUD) during perinatal (during and shortly after pregnancy). We propose to develop VisitBoost, an integrated technological solution that provides organizational leadership and home visitors with opportunities for assessing current practices, education to transform existing approaches, and ongoing support for reflection and practice. Stigma reduction within home visiting programs will lead to improvements in client satisfaction, increased client engagement, and improved parent and infant health and well-being, including reductions in child welfare involvement and decreased intergenerational transmission of SUD.